Investigating mechanisms of cell volume regulation in the zebrafish notochord

Abstract
Animal cells achieve and maintain a typical volume through the regulation of ion channels that control osmotic
processes. In metazoans, development of properly proportioned bodies also requires volume regulation to be
coordinated amongst cells within tissues and across organs and systems. Although ion channels regulating cell
volume have been identified in cells in culture, little is known about the mechanisms that regulate cell volume
and coordinate volume control throughout whole tissues in vivo. Our proposed studies will investigate in zebrafish
a new and conserved pathway controlling cell volume and integrity in vacuolated cells of the notochord. Using
genetic, cell biological, physiological, and quantitative in vivo and ex vivo approaches, we will define the
physiological mechanisms regulating fluid transport and cell volume in response to mechanical cues.

Public health relevance
Public Health Relevance The proposed studies will investigate cellular and physiological mechanisms regulating cell volume and cell integrity in notochord vacuolated cells and in vacuolated cells rom the nucleus pulposus of intervertebral discs (IVD). These studies are relevant for the understanding of spine biology and IVD disease.